Seq-Scope: Microscopic Examination of Spatial Single Cell Transcriptome in Cell and Tissue Senescence

ABSTRACT
The parent grant (UG3/UH3CA268091) aims to develop a high-resolution, cost-effective spatial transcriptomics
tool for detecting and characterizing senescent cells and their microenvironment in intact tissues. Building on
our initial proof-of-concept Seq-Scope prototype, which exhibited orders of magnitude improvements over
existing spatial technologies at the time, we have made substantial advancements in both the experimental
and computational workflows, enhancing robustness, accessibility, and precision. We expanded Seq-Scope’s
imaging area by leveraging sequencing flow cells with larger capacities (e.g., Illumina NovaSeq 6000) and
optimized a cost-effective Seq-Scope protocol for generating high-resolution spatial data. Additionally, we
developed FICTURE, a computational algorithm that preserves Seq-Scope’s original high-resolution spatial
data without requiring cell segmentation or pixel binning. These advancements have significantly impacted
various SenNet programs, fostering collaborations to study cellular senescence in diverse contexts.
Furthermore, FICTURE’s platform-independent framework enables its application across both sequencing- and
imaging-based spatial transcriptomics technologies, broadening its utility. Recently, we achieved another major
technological breakthrough by integrating Seq-Scope with tissue expansion, dramatically surpassing optical
resolution limits in a new platform tentatively named Seq-Scope-eXpanded (Seq-Scope-X). In addition to its
unprecedented resolution, Seq-Scope-X demonstrates enhanced compatibility with multi-omics applications,
enabling the profiling of over 100 protein expression patterns in a single experiment using antibody-tagged
oligos. This supplement seeks to capitalize on these unanticipated advancements to deepen our
understanding of cellular and tissue senescence across various physiological contexts. Specifically, we
propose to: (1) evaluate Seq-Scope-X’s tissue compatibility by applying it to diverse mouse and human
tissues, (2) integrate barcode-encoded senescence markers into Seq-Scope-X’s proteome detection workflow
to simultaneously profile transcriptomes, immune surface proteomes, and senescence markers, (3) examine
mouse liver tissues under various physiological and pathological conditions to assess the contribution of
senescence to disease progression, and (4) characterize nuclear vs. cytoplasmic transcriptomes using Seq-
Scope-X to distinguish between present (cytoplasmic) and future (nuclear) transcriptomic states, shedding light
on the reversibility of senescence and its role in cellular phenotype transitions over time. By refining Seq-
Scope-X’s resolution, multi-omic integration, and analytical capacity, this supplement will significantly enhance
our ability to characterize senescent cells and their functional impact on tissue homeostasis and disease.
These advancements will not only benefit SenNet initiatives but also contribute broadly to the fields of spatial
transcriptomics and cellular senescence research.

Public health relevance
PROJECT NARRATIVE The parent project aimed to adapt Seq-Scope for detecting and characterizing senescent cells in normal human tissue. The unexpected development of Seq-Scope-X, a breakthrough in nanoscale spatial transcriptomics, necessitates additional experiments to evaluate its utility for senescence-related spatial analysis, which this administrative supplement will support.